2023 Cancer Nanotechnology Gordon Research Conference and Gordon Research Seminar

Abstract
The 2023 Cancer Nanotechnology Gordon Research Conference (CN-GRC) provides a unique and highly
acclaimed forum where scientists at every stage of their career can share unpublished, innovative cancer
research made possible by the use of nanotechnology. Held biennially since 2011, the conference has had a
strong and steadily growing attendance. To further support the emerging generation of scientists in this field,
the Cancer Nanotechnology Gordon Research Seminar (CN-GRS) will be carried out in conjunction with the
GRC, highlighting talks by graduate students and postdocs. This conference is an important venue bringing
together chemists, physicists, engineers, biologists, clinicians, industry leaders and regulatory experts focused
on the highly interdisciplinary science of cancer nanotechnology. This meeting will particularly focus on two
ends of the spectrum in cancer research: deepening our fundamental understanding of the interactions of
nanomaterials with tumors and the in vivo environment, and translation of cancer nanotechnology out of the lab
and into the clinic.
The conference will bring together a lively group of exceptional scientists to peaceful and scenic Waterville
Valley, NH in order to: 1) share cutting-edge research in cancer nanotechnology by experts representing the
whole spectrum of life sciences; 2) foster discussion, exchange of ideas, and promote collaborations and 3)
enhance the training and development of young scientists and promote diversity. A high priority of the CN-GRC
and CN- GRS is to increase the diversity of participants. Towards this goal, funds are requested for travel and
registration support of female and under-represented speaker

Public health relevance
Project Narrative The goal of Gordon Research Conference & Seminar on Cancer Nanotechnology is to provide a platform for internationally renowned and early career scientists to discuss recent breakthroughs in the use of nanotechnology for the diagnosis and treatment of cancer. This forum will focus on new aspects of cancer biology, immunology, imaging, and therapy and showcase the work of a diverse group of experts from across the spectrum of life sciences. Furthermore, the addition of the Cancer Nanotechnology Gordon Research Seminar (CN-GRS) will help in the development of young cancer nanotechnology investigators and highlight their contribution to the field.